Admin-Core

Project Summary/Abstract: Administrative Core
The objectives of the Administrative Core are to provide administrative support for the Resource Cores,
coordinate and facilitate communication between Center investigators and the Cores, establish an Advisory
Committee that will provide long term vision, establish a Diversity Committee to guide Diversity Initiatives, and
carry out other Outreach Activities. This is a Center that both draws in, bringing visiting scholars to Harvard for
training in human-based techniques and bringing new investigators into human skin disease research, and a
Center that pushes out, exporting knowledge and the ability to use new and powerful approaches to members
of the scientific community. The Administrative Core supports the Center Director and Associate Director, who
provide the leadership necessary to establish a dynamic and flexible Center that can rapidly respond to the
changing landscape of science, remaining state-of-the-art and responsive to users' needs. The Administrative
Core establishes and supports the Advisory Committee, composed of internal and external experts in human
translational research who have leadership experience with complex multi-center grants. This Center renewal
makes a commitment to supporting diversity. This Core will establish and support a Diversity Committee, led
and composed of people of color and other underrepresented individuals in science and medicine, who will
mentor trainees and coordinate the Center’s Diversity Initiatives. The Center will fund research fellowships for
underrepresented minority (URM) high school students, undergraduates, graduate students, medical students,
residents and postdoctoral fellows, drawing them into human skin disease research, establishing mentorship
relationships and supporting them beyond the duration of their projects. Other Outreach activities include
sponsorship of the biennial International Conference on Human Skin Diseases that will present cutting-edge
human skin disease research by internationally recognized investigators and will also serve to publicize Center
services and the results of Center Investigators, as well as quarterly podcasts, webcasts, instructional videos
and other electronic outreach activities. In summary, the Administrative Core provides vision and leadership to
the Center, coordinates and centralizes the activities of the Resource Cores, and administers Outreach
activities that publicize the Center activities, support skin disease researchers and bring new diverse
researchers into the field of human skin disease research.